Mechanisms of sigma-factor-dependent transcriptional control in Mycobacterium tuberculosis

PROJECT SUMMARY
Mycobacterium tuberculosis (Mtb) causes 1.6 million tuberculosis (TB) related deaths per year, and current TB
therapeutic strategies are becoming inadequate due to the emergence of drug resistant strains. One of the
primary antibiotics used to treat TB infection acts at the level of transcription, inhibiting the RNA polymerase
(RNAP). Sigma factors (σ) are accessory subunits that associate with the RNAP, directing a transcription-
competent RNAP holoenzyme to unique genes. The σA RNAP holoenzyme is responsible for transcribing the
majority of the Mtb genome, and as such, represents the major RNAP-dependent drug target. Of all the σs found
in Mtb, only σA contains a N-terminal intrinsically disordered region (IDR) with strong charge segregation (i.e.
clustering of positively/negatively charged residues). The propensity for disorder and charge segregation is
conserved not only across mycobacteria, but more broadly across the whole Actinobacteria phylum, suggesting
a functional, yet uncharacterized role of these σA IDRs in bacteria. This proposal seeks to understand the role of
the Mtb σA IDR in transcriptional regulation, assessing what sequence and conformational features of the IDR
encode functionality.
Leveraging both experimental and computational approaches that overcome the technical challenges associated
with the structural characterization of IDRs, I will assess how the conformational dynamics and interactions of
the σA IDR impart transcriptional activity. I will employ a combination of in vitro kinetic measurements for
transcriptional activity, single-molecule fluorescence techniques for measurements of IDR conformations and
dynamics, and molecular dynamics simulations and cross-linking mass spectrometry for identifying IDR-
mediated interactions within the RNAP holoenzyme. Measurements will specifically investigate the role of
charge-segregated disordered regions and post-translational modifications and be performed under conditions
that mimic intracellular ionic concentrations during Mtb infection and in the presence/absence of antibiotics.
Given the broad conservation of sequence features, conclusions made will likely be applicable beyond Mtb,
leading to a new paradigm for how bacteria use IDRs in transcription.
The research and training objectives in this proposal will further the understanding of mechanisms of gene
regulation unique to disease-causing bacteria, while enabling me to obtain additional technical training to foster
the future generation of academic biomedical investigators.

Public health relevance
PROJECT NARRATIVE Sigma-factors are critical protein components of the bacterial transcription machinery, reprograming the transcriptome to adapt to different environmental cues and stresses encountered from the host. The primary sigma-factor in Mycobacterium tuberculosis (Mtb), the causative bacterial agent of tuberculosis (TB), contains an intrinsically disordered region (IDR) of unknown function. The proposed work will evaluate the structural dynamics and function of this IDR, in effort to understand its role in Mtb transcriptional regulation and bacterial resistance against the current primary antibiotic used to treat TB infections.